Administrative Core

The Administrative Component will assure the effectiveness of the DRC in meeting the center’s stated goals
and specific aims. This component includes the Administrative Core, the Pilot & Feasibility Grant Program, and
the Enrichment & Training Program. The DRC will be directed by W. Timothy Garvey MD, assisted by associate
directors Drs. Barbara Gower, Anath Shalev, and Andrea Cherrington. The Director and Associate Directors will
be joined by other key DRC faculty in comprising the DRC Executive Committee, Drs. Stuart Frank and Kirk
Habeggar. The ultimate goal of the Administrative Core is to assure the growing vitality of an intellectual
community and a highly productive research program in diabetes, by effective deployment of DRC
resources, for the benefit of our members, trainees, patients, and community.
Operationally, the Core will assure productivity and effectiveness of DRC activities including the biomedical
and translational research core facilities (Animal Physiology, Human Physiology, Interventions & Translational),
a pilot & feasibility grant program that promotes research progress of promising investigators and innovative
lines of investigation, and an enrichment program that advances the DRC as an intellectual community, promotes
interactions and discussions regarding new discoveries and concepts, provides a forum for the formation of
multidisciplinary collaborations, and establishes a dynamic educational environment for training and career
development. The Administrative Core will be responsible for the managing membership, the network of DRC
communications and website, bookkeeping, progress reports, quality control and evaluation, interface with
NIH/NIDDK, assurance of responsible fiscal management and regulatory compliance, and will obtain and
implement recommendations of Internal and External Review Committees.
Over the 14 years of UAB DRC existence, the Administrative Core has:
· Overseen a progressive increase in members, publications, research grant dollars, recruitment of new
faculty, and development of new research areas such as islet cell biology, sleep/circadian biology, and early life
influences on cardiometabolic disease that have enhanced and broadened the scope of our diabetes research.
· United areas of research excellence under the umbrella of diabetes and cardiometabolic disease and
established a cohesive intellectual community.
· Facilitated the evolution of the DRC by initiating new core services to meet investigator needs, an enrichment
program that introduces new ideas and scientific discoveries, career development of mentored members, and
development of new areas of research excellence.
Thus, the DRC will continue to exert a pronounced impact on diabetes research excellence at UAB and we
are confident that further evolution and growth will be achieved over the next 5 years.

Public health relevance
The Administrative Core will assure the effectiveness of the Diabetes Reseath Center (DRC) at the University of Alabama in meeting the center’s stated goals and specific aims, and will be directed by W. Timothy Garvey MD, assisted by associate directors Drs. Barbara Gower, Anath Shalev, and Andrea Cherrington. The Core will oversee the Pilot & Feasibility Grant Program, the Enrichment & Training Program, and the biomedical research core facilities. The ultimate goal of the Core is to assure the growing vitality of an intellectual community and a highly productive research program in diabetes for the benefit of our DRC members, trainees, patients, and community.